Ultrasound-based diagnostic and monitoring of bladder cancer treatment with drug released from nanoparticles

Project Summary/Abstract: Transitional cell carcinoma (TCC) of the bladder is the fifth most common form
of cancer in the U.S., with over 80,000 new cases expected in 2019. For early-stage carcinomas, patients
receive intravesical bacillus Calmette-Guerin (BCG) immunotherapy, or transurethral resection of the bladder
tumor (TURBT) with intravesical chemotherapy. Both are associated with a high rate of recurrence and
eventual progression. BCG fails many patients who are immunocompromised or who experience adverse
reactions, while TURBT with chemotherapy fails because the chemotherapeutic agent is not sufficiently
retained in the bladder to penetrate lesions that aren’t resected. Thus, there is a need for an improved drug
formulation for early-stage (CIS, Ta, T1, T2) TCC capable of 1) penetrating the tumor beyond the superficial
cell layers, and 2) increasing the dwell/contact time between the chemotherapeutic agent and the cancer cells.
To that end, NanoMedTrix (NMTx) has developed a particle based on mesoporous silica nanoparticles (MSN)
that carries known chemotherapeutic agents and is designed to improve their specificity, dwell time, and tumor
penetration. Our Phase I SBIR project exceeded our goals and demonstrated the safety and efficacy of the MSN
particles in carrying and releasing epirubicin in vivo in a murine TCC orthotopic model and in vitro using cultured
human TCC cells. Through our participation in the NIH I-CORPS program we spoke with key opinion leaders
(urologic oncologists) in the clinical bladder cancer space. As a result, we are completing our Phase I work using
the MSN to deliver clinically relevant doses of gemcitabine, docetaxel, and mitomycin-c in the same model.
Following our Phase I success, our Phase II SBIR is designed to complete the acquisition of data required by
the FDA for initiation of IND approval of NMTx MSN in human clinical trials. Specific Aim 1 describes the
necessary in vitro tasks: optimizing particle chemistry and validating our larger canine model using cultured cells
and canine TCC organoids. Specific Aim 2 describes completion of murine orthotopic studies and the start of
pre-clinical trials in dogs with spontaneously occurring TCC. Specific Aim 3 lays out our plan for carrying out
cGMP synthesis, packaging, and analysis of our IND.
Beyond setting the stage for FDA IND approval and first-in-human clinical trials, Phase II completion will
strengthen our position with investors/partners in the pharmaceutical industry, with whom we will partner in SBIR
Phase IIB, Phase III and beyond to expand clinical trials and ultimately commercialize the technology. We are
continuing to work with the urology contacts we made in I-CORPS who are eager to participate in clinical trials,
and we have received interest from Pharma companies (Bristol-Myers Squibb, Urovant, and others). Our
proprietary technology will provide licensees with improved performance from established chemotherapeutics
that have already gone off-patent, thus making our technology attractive both clinically and commercially.
Ultimate commercial success of this SBIR work will greatly benefit human health while reducing medical costs.

Public health relevance
Project Narrative In bladder cancer, BCG immunotherapy and intravesical chemotherapy are superficial and are associated with high rates of recurrence and progression; hence, there is a need for novel therapies that 1) are retained longer by the tumor cells specifically; and 2) penetrate the tumor to its origin in the detrusor muscle. In Phase I of our project all goals were met and exceeded, as we validated the ability of our novel nanomaterial to meet these needs in a mouse model. This Phase II project is designed to test this work using larger animals (the spontaneous canine TCC model) and to begin cGMP production/analytics as a key step toward first-in-human clinical trials.